Diabetes Endocrinology Research Center

DESCRIPTION (provided by applicant): The University of California at San Francisco Diabetes Center, an organized research unit at UCSF, has functioned for more than a half-century as a basic and clinical research enterprise at the forefront of diabetes research. Historically, the program has had an ongoing enrichment program, Pilot & Feasibility studies, strong basic science and clinical research interface. The goal of the Center is to support a highly interactive team involved either directly or indirectly in Type 1 and Type 2 diabetes research to advance the study and treatment of the disease. In this application, the UCSF Diabetes Center proposes to establish a Diabetes Research and Training Center (DRTC) that will support Core Laboratories, an Enrichment Program and Pilot and Feasibility studies. The Center will encompass a broad range of intellectual and research expertise from over 12 departments and organized research units and three UCSF campuses focused on basic research with an eye towards clinical application. The center will combine immunology, metabolic research, cell biology and genetics in the field of diabetes to develop unique approaches to understand and treat this devastating disease. Investigators of the DRTC are organized in the following programmatic areas: Cell Biology of Islets, Developmental Biology, Islet Transplantation and Immunology, Autoimmunity, Receptors and Signaling, and Obesity & Metabolism and Obesity, Complications of Diabetes. Seven Core facilities are designed to facilitate interdisciplinary investigations of these scientists ( Enrichment Core, Islet Production Facility Core, Microscopy & Cellular Imaging Core, Genomics & Bioinformatics Core, Mouse Genetics Core, Mouse Metabolism, and Human Metabolism Cores). A Pilot and Feasibility Grant Program serves to foster new initiatives in diabetes research primarily of junior faculty and those senior faculty from outside the diabetes focus area. An intensive academic enrichment program which organizes seminars and various symposia is designed to keep Center investigators abreast of the latest discoveries and to maintain the research program at this center at the forefront of biomedical science.